Geospatial Data Analysis Core

PROJECT SUMMARY GEOSPATIAL DATA ANALYSIS CORE
The overall goal of the Geospatial Data Analysis Core (GDAC) is to support the ongoing data development and
associated analytic and computing needs of the UIC Center for Climate and Health Equity (CECHE). The
GDAC will support the multi-disciplinary team of scientists working on the Research Project and pilot projects,
work closely with the Community Engagement and Outreach Core (CEOC) throughout the project period, and
establish priorities in coordination with the CECHE Director and Administrative Core. The specific aims of the
GDAC are to: 1) building on spatial analytics and data-science expertise, prepare and provide innovative
nature-based, climate and health-related spatiotemporal datasets and bridge multidisciplinary CECHE
investigators including climate science, population-health, exposure science, engineering, urban planning, and
health policy; 2) enable state-of-the-art, epidemiological, statistical, and spatio-temporal analytics to advance
innovative climate and health research in Chicago and across the nation; 3) support the work of the CEOC and
research project investigators, and support the CEOC by providing meaningful and accessible materials on the
results emanating from CECHE; and 4) provide capacity building for communities through a Climate Health
Institute in collaboration with the COEC and key community-based partners to create and sustain a Climate
Health Institute to train citizen scientists, advance data collection and interpretation, and enhance
environmental health literacy. By providing novel climate-related exposure and health data resources,
developing advanced spatio-temporal data architectures, coordinating spatial analysis, statistical support, and
community engagement and capacity building, the GDAC will facilitate interdisciplinary collaborations, respond
to community needs, and play a vital role in advancing climate and health equity.